Determinants of transdermal drug delivery to the normal and the radiated breast

Duct carcinoma in situ (DCIS) of the breast comprises about 20% of new breast malignancies in screened
populations. Treatment consists of breast conserving surgery (BCS) in about 75% of women, usually followed
by (RT), which halves the risk of new cancer events on the same side. Oral endocrine therapy (OET) further
reduces the risk to the same breast by 1/3rd , and cuts the risk to the other breast by one-half. However, OET is
declined by more than half of DCIS patients, given its thromboembolic and uterine risks (selective estrogen
receptor modulators), and musculoskeletal effects (aromatase inhibitors). Drug delivery methods that avoid the
adverse effects of these agents will represent a significant advance. Transdermal delivery is a well-recognized
and effective alternative. Advantages include low systemic exposure, longer retention in the local tissue, and
avoidance of first-pass hepatic metabolism.
Encouraging preliminary data on local transdermal therapy (LTT) with 4-hydroxytamoxifen (4-OHT) applied
to the breast skin have led us to conduct clinical trials aimed at establishing the equivalence of transdermal and
oral treatment of the breast. If successful, this will be a novel and potentially transformative development for
the DCIS population, and for women at high risk for breast cancer. However, there are significant knowledge
gaps regarding the causes of individual variations in dermal permeation. And current studies exclude women
who have undergone breast RT because this may alter dermal permeation and/or distribution through the
breast. Since DCIS patients who receive RT breast derive additional protection for both breasts through the use
of OET, an evaluation of drug permeation through radiated skin is important.
The Aims of our study are 1) to identify the skin features that drive inter-individual variation in dermal
drug permeation between individuals, and 2) to assess the feasibility of transdermal drug delivery to the
radiated breast. We will do this by enrolling breast cancer survivors who have one radiated and one intact, non-
radiated breast, and are willing to apply 4-OHT gel to both breasts for a period of 3-5 weeks. We will then
obtain skin punch and core needle biopsies of both breasts, measure drug concentration in the breast tissue
cores, and assess individual characteristics (breast size, adiposity) and skin features (thickness of skin layers,
gene and protein expression) that may explain the inter-individual variation in drug concentration. In Aim 1,
these features will be used to develop a predictive model that identifies the important determinants of dermal
drug delivery in the unradiated breast. In Aim 2, skin features will be compared between the radiated and
unradiated breast, to determine differences introduced by radiation that are important for dermal permeation.
Drug concentrations will be compared between the radiated and unradiated breast. At the end, we will answer
two questions regarding which little information exists currently: 1) which women are good candidates for
transdermal therapy? 2) Will transdermal delivery work for the radiated breast?

Public health relevance
Breast cancer prevention is possible through use of one of several anti-hormone pills that have been tested in clinical trials, but many women are reluctant to use these because of concerns about side effects. A new concept for breast cancer prevention is that of putting medications in a gel that can be applied to the breast skin, rather than taking a pill. In this trial, we will test one such medicated gel (4- hydroxytamoxifen) in women treated for breast cancer, who have finished breast radiation, to better understand which women are likely to benefit from this treatment, and whether the radiated breast can also be treated in this way.